Role of the COP9 Signalosome (CSN) in kidney disease and hypertension

Project Summary / Abstract
Hypertension is the most common risk factor for heart disease and stroke; therefore, it is important to understand
the pathogenesis of hypertension for better prevention and treatment. Rare Mendelian causes of hypertension
identify previously unrecognized physiological pathways and networks, which can illuminate new treatments for
disease. The Mendelian syndrome Familial Hyperkalemic Hypertension (FHHt, or pseudohypoaldosteronism
type II) is a monogenic disease resulting from mutations which increase expression of with-no-lysine kinases
(WNKs). Cullin-RING ligases (CRLs) were recently discovered to regulate blood pressure via proteasomal
degradation of WNKs. Regulation of CRL activity is facilitated by the deneddylase, COP9 Signalosome (CSN),
which binds to the complex and removes the ubiquitin-like protein, NEDD8. A mutation in cullin 3 (CUL3) causes
FHHt and was shown, by in vitro analysis, to have enhanced CUL3 neddylation, increased degradation of the
substrate adaptor kelch-like 3 (KLHL3), and decreased binding to the CSN. We hypothesized that the impaired
interaction with the CSN was integral to the disease. The CSN is a well-studied multi-subunit protein, but the
data here provides the first evidence that disordered CSN activity in the kidney may relate to hypertension and
chronic kidney disease (CKD). The applicant has characterized a genetic mouse model of CSN dysfunction, in
which the catalytic subunit of the CSN, Jab1 is deleted from kidney-tubule cells (KS-Jab1-/-). These mice
developed an unusual phenotype; there was decreased KLHL3 and upregulation of the WNK-SPAK pathway
akin to FHHt, however, several unexpected consequences of Jab1 deletion throughout the nephron were noted
that made the observed phenotype differ from the human disease. This included a decrease in the abundance
of the Na-Cl co-transporter (NCC) after several weeks, and progressive and spontaneous kidney fibrosis,
mimicking chronic kidney disease. Here, the applicant proposes to further explore these provocative results in
three specific aims. Aim 1 will continue to test the hypothesis that impaired CSN function causes FHHt by
generating mouse models that more faithfully mimic the disease mutation. In Aim 2, a combination of in vitro and
in vivo techniques will be used to determine whether the CSN plays a role in modulating NCC directly. Aim 3 will
examine the kidney damage caused by deletion of Jab1. Nrf2 accumulation will be investigated as a possible
mechanism for the damage by generating Jab1 and Nrf2 double knockout mice. In addition to successful
completion of these aims the mentoring and scientific environment make the applicant an ideal candidate to
develop independence in renal physiology research. The proposed research will help reveal the mechanisms
involved in regulation of blood pressure through the CUL3-KLHL3-WNK4 pathway which could lead to
pharmaceutical treatment of hypertension by targeting CRLs, or the CSN. The results will also open two entirely
new areas of focus, the role that the CSN plays in regulating NCC degradation and the potential role played by
the CSN in mediating or accelerating the development of chronic kidney disease.

Public health relevance
Project Narrative High blood pressure (hypertension), caused in some cases by genetic mutations such as in Familial Hyperkalemic Hypertension (FHHt), is a great burden to public health both medically and financially. The kidney tubules are the main site in the body that adjusts body salt content, and by doing so, helps to set the blood pressure to an optimal level. The proposed research investigates the molecular mechanism behind a newly discovered genetic mutation that causes FHHt and may lead to the development of new drugs or cost- efficient treatments to target hypertension.